VALIDATION AND APPLICATION OF NONSTEADY-STATE EQUATIONS

Using a dual isotope technique to experimentally determine the effective volume of distribution of glucose during a hyperinsulinemic euglycemic clamp.